Flow Cytometry and Cell Sorting

FLOW CYTOMETRY AND CELL SORTING SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Flow Cytometry and Cell Sorting shared resource (Flow) provides investigators with rapid and precise
multiparameter analysis of cells and particles. The overall purpose of the shared resource is to provide
access to high-end technologies and expert assistance with various techniques in flow cytometry and cell
sorting to members of CINJ.
Under the leadership of Dr. Edmund C. Lattime, Flow provides CINJ members with an array of powerful flow
cytometry and cell sorting instrumentation and techniques, expert consultation for detailed protocols and
experimental design to optimize data generation, and expert consultation in data analysis, presentation, and
publication. Flow provides state-of-the-art digital instrumentation maintained at the highest standards.
Consistent attention to quality control allows researchers to sort cells at high efficiency and purity under the
proper conditions or to run analytical experiments with as many as 12 different fluorochromes simultaneously.
Flow is dedicated to providing the best service and training possible for their scientific members. The shared
resource provides a convenient cost-effective facility that continues to generate important scientific results.
Flow has been an ever-evolving mainstay of research at CINJ, originating with the Rutgers facility established
in 1986. Today, Flow has full-service sites at Rutgers in New Brunswick and at Princeton University, and is
used extensively by CINJ members.